Local Circuit Control of Rapid Plasticity and Tunable Ensemble Formation in the Hippocampus

Project Summary/Abstract
Neural representations supporting spatial and episodic learning form, and transform rapidly in the mammalian
hippocampus. Individual hippocampal pyramidal cells each fire at a specific location in an environment and
together these place cells provide a striking substrate for a cognitive map. A critical step in achieving a
mechanistic understanding of how place cell dynamics support hippocampal learning and memory is to be able
to re-create endogenous neuronal representations experimentally, and test their behavioral relevance.
However, it has not previously been possible to generate lasting hippocampal place cell maps through
controlled manipulations of hippocampal plasticity. Our groups have recently identified key potential controllers
of hippocampal ensemble formation, raising the intriguing possibility that stable place cell maps can be
synthetically generated and allocated by manipulating these controllers. In particular, we demonstrated that
any individual, arbitrarily chosen pyramidal cell in the mouse hippocampal area CA1 can be reliably induced to
become lasting place cells, using all-optical plasticity induction. Here, we propose to determine if targeted in
vivo manipulations of feedback inhibitory (Aim 1), recurrent excitatory (Aim 2), and cell-intrinsic retrograde (Aim
3) local circuit control mechanisms enable the specific generation and allocation of behaviorally relevant neural
representation by scaling single-cell optogenetic place cell induction to multi-cellular ensembles. We will test
our hypothesis in the hippocampal area CA1 of mice navigating and learning in a virtual reality environment,
utilizing a variety of innovative in vivo calcium-imaging, optogenetic, electrophysiology, statistical data analysis,
and modeling approaches. We anticipate that our project will have a significant, potentially translatable impact
by overcoming major knowledge gaps about cellular and local circuit determinants of neuronal plasticity, while
also supporting rapid induced plasticity of neuronal representations. Our research can thereby accelerate the
development of neural modulation strategies to study, modify, or improve memory-related behaviors.

Public health relevance
Project Narrative Neuronal plasticity in the hippocampus supports episodic and spatial learning. However, the neural mechanism underlying rapid and flexible formation, and later transformation of hippocampal neuronal representations remain poorly understood. Our project will determine how key local circuit controllers of learning-related plasticity can be utilized to generate lasting neuronal representations that support memory-guided behaviors.